Preparing IND filing for novel lung cancer therapeutic

Project Summary Abstract
Quench Medical's unique chemotherapeutic inhalation formulation is intended to significantly improve the
control of tumors and the survival of patients while minimizing systemic toxicity. Five-year survival rates are 20%,
two-thirds of patients do not qualify for “gold standard” surgery, and systemically administered chemotherapy
drugs deliver a low drug concentration to the lungs due to blood volume dilution and metabolism. Local aerosol
delivery to the lung can bypass the systemic drug delivery limitations and is a strategy that has been shown to
significantly improve the control of pulmonary tumors. Therefore, we are developing an efficient and targeted
inhaled dry powder aerosol formulation to better treat patients with lung cancer.
This CRP project will complete the regulatory data required for investigational new drug (IND) filing of
QM-269 to the Food and Drug Administration (FDA) Division of Oncology. The efforts in this proposal continue
the commercial translation of a new type of targeted lung cancer treatment with a highly efficient and novel dry
powder formulation that is optimized to maximize efficacy and minimize toxicity to significantly improve treatment
for patients with non-small cell lung cancer. Together with the ongoing Phase II SBIR efforts, we have identified
a clear path to clinical study, 505(b)(2) FDA approval, and marketing. The commercialization readiness
milestones in this project will allow for immediate FDA regulatory IND filing to begin first-in-human clinical testing
of QM-269.

Public health relevance
Project Narrative Lung cancer is the leading cause of cancer mortality with a 5-year survival rate of 20% following standard of care treatment. There is strong evidence that targeted delivery of inhaled chemotherapy medication to the lung at a fraction of the current dose will have a major impact on increasing survival and reducing lung tumor burden in lung cancer patients with far less side effects than those associated with current systemic intravenous chemotherapy. Based on preliminary data and ongoing efforts, we will complete essential tasks to develop a novel inhaled chemotherapy treatment to directly target pulmonary tumors to improve survival in lung cancer patients. The commercialization readiness milestones achieved in this project will allow for immediate investigational new drug (IND) filing with the FDA to begin first-in-human clinical testing.